ILEAL POUCH ADAPTATION AND DYSFUNCTION FOLLOWING COLECTOMY

This study evaluates the adaptation and functional outcome following colectomy with ileal pouch anal anastomosis, particularly the role of bile acids, prostaglandins and leukotrienes in ileal pouch dysfunction.